Connectome-Based Prediction of Addiction Severity

7. Abstract
The United States is currently facing an epidemic of fatalities associated with the use of multiple types of
substances. Given this public health crisis, there is an urgent need to identify transdiagnostic, dimensional
biomarkers of substance use disorders (SUDs). In the field of clinical neuroscience, traditional, group-level
functional magnetic resonance imaging (fMRI) approaches have struggled to identify predictive biomarkers of
addiction that replicate across samples, possibly due to methods that (a) overfit the data and (b) examine
different SUDs in isolation. To address this, the first objective of this application is to leverage recent advances
in connectome-based predictive modeling (CPM), a data-driven machine-learning approach, to identify
patterns of functional connectivity (“neural fingerprints”) that are predictive of a transdiagnostic, dimensional
measure of SUD severity at the individual level. Further, as opposed to single-modality research, NIDA has
outlined the need to examine the complex interactions of factors across biological, psychological, and
environmental domains (Priority Focus #1) in order to understand the real-word complexity of SUD vulnerability
(Priority Focus #3). In line with these priorities, the second objective of this application is to integrate
SUD-related whole-brain metrics into multilevel models of addiction vulnerability that include well-established
psychological and environmental risk factors. The proposed research will make use of archival data collected
as part of two independent studies (N = 242). Clinical assessments, self-report data, and resting-state fMRI
data were collected from a diverse sample of community adults, elevated on illicit drug use, with 43% meeting
criteria for a lifetime SUD and 81% reporting a history of illicit drug use. We hypothesize that a CPM-derived
neural network will emerge in relation to SUD severity in the training sample that can be used to accurately
predict SUD severity in another independent sample (Aim #1). This is expected to produce a working neural
model that can be further tested and applied to make highly-individualized predictions of SUD severity in other,
unseen samples. Next, we hypothesize that these networks will contribute unique variance to a multi-faceted
model of addiction vulnerability, above and beyond well-established psychological and environmental risk
factors (Aim #2). The integration of knowledge across multiple domains makes this application well-situated to
address the real-world complexity of SUDs, and thus presents an opportunity for significant advances towards
the development of precision medicine methods. This F31 application will provide opportunities for the
applicant’s training in two critical areas: (a) the technical skills necessary to implement machine learning
approaches to isolate brain networks with predictive power to identify individual differences in SUD severity
and (b) the conceptualization and design of multi-faceted models that incorporate factors from multiple
domains of analysis to characterize addiction vulnerability.

Public health relevance
8. Project Narrative Although extant human neuroimaging research has identified a number of aberrant brain networks associated with addiction, it has struggled to produce reliable predictive biomarkers of substance use disorders (SUDs). To address this, the objective of this application is to leverage recent advances in connectome-based predictive modeling (CPM) to identify functional neural networks that are predictive of SUD severity at the individual level, and to test the relative contribution of these novel neural metrics in integrated models of latent addiction vulnerability. The proposed training and research plans are intended to advance understanding of the multidimensional nature of addiction and further develop the applicants’ program of research that seeks to elucidate the biopsychosocial processes underlying addiction.